SYNCHROTRON--SUPEROXIDE DISMUTASE, DIPHTHERIA TOXIN, DE NOVO DESIGNED PEPTIDES

Amyotrophic lateral sclerosis (ALS or Lou Gehrig's disease) is neurodegenerative disorder characterized by the progressive destruction of large motor neurons in the spinal cord and brain. Approximately 10% of ALS-afflicted individuals having the inherited (familial) form of the disease (FALS) display tight genetic linkage between the disorder and a gene encoding a cytosolic Cu/Zn-binding superoxide dismutase (SOD1). We desire to correlate ALS misfunction withCu/ZnSOD structure via crystallographic analysis of human SOD mutants found in FALS patients.